USING EEG COMPLEXITY AND HIGH PERFORMANCE COMPUTING TO PROFILE SLEEP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Dr John Rand, at Kapiolani Community College, has a research interest in the profiling of sleep using high performance computing to deconvolve the complex signals embedded in EEGs.